Assessing skin biomarkers for preclinical diagnosis of PD and non-PD Parkinsonism

ABSTRACT
The disease-associated alpha-synuclein (αSynD) that accumulates and deposits as misfolded protein
aggregates in the brain is the pathological hallmark of Parkinson disease (PD), and also of other
synucleinopathies causing non-PD parkinsonism such as multiple system atrophy (MSA) and dementia with
Lewy bodies (DLB). Currently, a definitive diagnosis of these disorders often requires the detection of αSynD in
autopsy brain samples. An unmet medical need for PD and non-PD parkinsonism is to identify biomarkers for
diagnosis, defining disease severity, and assessing potential neuroprotective therapeutics in easily accessible
specimens. Notably, aSynD has been observed in the skin of PD patients by immunohistochemistry or
immunofl3`2uorescence microscopy whereas the sensitivity varied dramatically from 0-100%. Remarkably,
using the ultrasensitive assay termed real-time quaking-induced conversion (RT-QuIC), our recent preliminary
studies have shown that the αSynD-specific seeding activity is readily detectable in autopsy skin tissues of PD
patients with 100% specificity and sensitivity. Moreover, the protein misfolding cyclic amplification (PMCA),
another highly sensitive assay that detects αSynD seeding activity even in formaldehyde-fixed brain tissue of a
MSA patient, is also able to detect skin αSynD seeding activity in PD patients but not in non-PD controls. We
hypothesize that RT-QuIC and PMCA are highly sensitive and robust platforms to establish skin αSynD
as a biomarker for postmortem and premortem diagnoses of PD. To test this hypothesis, the following
three Aims will be pursued: (1) to establish skin aSynD as a biomarker for postmortem diagnosis of PD; (2)
Assess skin SynD as a biomarker for premortem diagnosis and defining PD severity using RT-QuIC and
PMCA; and (3) Determine skin αSynD as a biomarker for diagnosis of non-PD synucleinopathies such as MSA
and DLB as well as differentiate synucleinopathies from tauopathies such as corticobasal degeneration and
progressive supranuclear palsy. We believe that new knowledge generated from this study will further apply to
other neurodegenerative diseases including the most common neurodegenerative disease Alzheimer's
disease, where the disease-specific misfolded proteins such as tau protein and Aβ peptides have been also
found in the skin of affected patients.

Public health relevance
PROJECT NARRATIVE Our recent studies indicate that skin samples of patients with Creutzfeldt-Jakob disease, a neurodegenerative disease associated with the deposition of a misfolded protein aggregate (PrPSc), exhibit detectable PrPSc. The aim of our proposal is to extend our preliminary findings that skin tissues also contain the misfolded α- synuclein protein (αSynD) associated with Parkinson's disease (PD), the second most common neurodegenerative disease to address a critical issue whether the skin αSynD can be a biomarker for premortem and postmortem diagnostic tests for PD. We expect that our study will not only provide insights into PD but also other common neurodegenerative diseases such as Alzheimer's disease.